BACTERIAL FUNCTION INVOLVED IN CELL GROWTH CONTROL

We have continued studies on the role that energy-dependent protein degradation plays in regulating gene expression, using Escherichia coli as a model system. RssB, a protein that regulates the degradation of the stationary phase sigma factor RpoS has been found to regulate RpoS activity as well as degradation. Extracts overproducing RssB but not those devoid of RssB are able to stimulate the ClpXP-dependent degradation of RpoS, allowing the development of an assay for purification, to lead to detailed study of the factors that stimulate degradation. RpoS translation is regulated by DsrA, a small stable 85 nucleotide RNA. Mutational analysis indicates that a stem-loop at the 5' end of the RNA is necessary for regulation of RpoS, and shows homology to a region of the untranslated leader of RpoS that has been implicated in translational regulation. This suggests that pairing between the DsrA RNA and the RpoS leader opens up the leader structure, allowing translation. The second activity of DsrA, overcoming the silencing associated with the nucleoid associated HNS protein, is independent of the first stem-loop, demonstrating that this RNA has two distinct activities. We have used cI-HNS hybrid proteins, in which immunity to bacteriophage lambda depends on oligomerization between the HNS domains, to demonstrate that anti-silencing works by disrupting HNS oligomerization. DsrA and other small RNAs are gaining increasing recognition as novel regulatory molecules. In studies on the degradation of the lambda Xis protein, we find that it is subject to degradation by two distinct E. coli ATP-dependent proteases, Lon and FtsH. Rapid degradation of Xis helps insure rapid and stable lysogenization by lambda. In mutagenesis studies of the Lon protease, we find that deletions and point mutations in the C-terminal domain that remove or inactivate the proteolytic active site are still able to partially complement lon mutants when overproduced. This appears to be because the substrate binding domain is retained in the N-terminus of the deleted proteins, and binding of substrate is sufficient to interfere with substrate function, mimicking the effect of degradation. This will allow the analysis of substrate recognition and binding by the Lon protease to be studied independently of protein degradation.